RADX TECH PROJECT NO. 2320 - UNIVERSITY OF CALIFORNIA, LOS ANGELES - SWABSEQ

SwabSeq is a sequencing-based RNA detection method on the illumina platform that uses an in vitro RNA spike-in to achieve better quantitation and handle dirtier samples. SwabSeq is very simple, cheap, sensitive, quantitative, and scalable.